Lead identification and pre-clinical studies on allosteric inhibitors of coagulation factor XIa

Anticoagulants are the mainstay in the treatment of thrombotic diseases, such as heart attack and stroke,
and may also be used in other diseases such as cancer and COVID-19. Although several anticoagulants
including heparins, warfarin, and direct oral anticoagulants (DOACs) are used in the clinic, each agent suffers
from major and minor bleeding adverse effects. As of now, a safe anticoagulant that inhibits coagulation without
bleeding risk has not been developed as yet. Under the NHLBI's R01 mechanism, we earlier discovered that the
heparin-binding exosite 2 of human factor XIa (hFXIa) is remarkably different from other homologous coagulation
proteases (e.g., hFIIa, hFXa and others). We developed a novel design strategy that relies on anionic sulfates
and aromatic rings to effect highly selective recognition of hFXIa's exosite 2 resulting in inhibition of enzyme
activity. We developed a highly promising allosteric inhibitor, named sulfated D-chiro-inositol (SCI), which was
synthesized in four steps, displayed >100-fold selectivity for hFXIa; bound plasma FXIa in exosite 2 with an
affinity of 20–60 nM even when the enzyme's active site was covalently blocked; and inhibited in vivo arterial
and venous thrombosis in the rat at 250 µg per animal (~1 mg/kg) without enhancing tail bleeding. SCI was
tolerated at doses as high as 25 mg/rat suggesting a therapeutic window of ~100. SCI is a highly promising
anticoagulant; yet its pharmacokinetics is not the best. Using cues from heparin-based drugs, we hypothesize
that optimizing the number and position of sulfate groups on the D-chiro inositol scaffold, while also screening
its various stereoisomers would improve hFXIa affinity, inhibition potency, PK, pharmacodynamics (PD), and
chemistry, manufacturing and controls (CMC) properties before embarking on IND-enabling studies. The current
proposal focuses on studying a library of 20 rationally designed SCI analogs with the goal of identifying at least
one LEAD AGENT for advanced stage pre-clinical development. The specific aims are 1) synthesis,
anticoagulation efficacy, and bleeding of 20 putative factor XIa inhibitors based on the SCI structure; 2) in vivo
antithrombotic efficacy, DMPK, in vitro and in vivo toxicity of inhibitors; and 3) scaled-up non-GMP synthesis,
CMC, dose escalation efficacy, and PD studies to identify one or two lead molecules. SCI has been claimed in
a US patent (#9,758,459 B2 titled `Allosteric modulators of factor XIa as anticoagulant agents') with the PI as
one of the inventors. Quantitative milestones with regard to synthesis, in vitro & in vivo efficacy, in vitro and in
vivo toxicity will be used to guide the transition from the R61 to R33 Phase. Alternatively, the best 1 (or 2) analogs
of SCI would be identified as the most promising agent for further IND-enabling studies starting from the 20
designed SCI analogs.

Public health relevance
PROJECT NARRATIVE Although several anticoagulants including heparins, warfarin, and direct oral anticoagulants are used in the clinic today, each suffers from major and minor bleeding adverse effects. The current proposal focuses on studying a library of 20 rationally designed analogs of a promising allosteric inhibitor of human factor XIa with the goal of identifying at least one lead agent devoid of enhanced bleeding risk for advanced stage pre-clinical development.